Fluoridated scaffolds for the treatment of critical-size bone defects

Bone grafts are used in various clinical settings to aid bone repair and regeneration. In recent years, the United
States, as well as other countries worldwide, have experienced an increasingly high demand for functional bone
grafts. This includes the US military and the VA healthcare systems, where there is a high demand for bone graft
substitutes to repair critical-size bone defects, fracture non-unions, and orthopedic reconstruction incidents to
battlefield trauma. Current repair processes use the patient’s own bone tissue harvested during reconstructive
surgery. However, autograft donor sites are limited in the amount of tissue available, and secondary surgical
sites are usually required. While allografts harvested from cadaveric sources eliminate the need for secondary
surgical sites and have the advantage of being osteoconductive, they are associated with the risk of host rejection
and accelerated graft resorption. The downsides of autograft and allograft bone techniques have impelled the
development of bioengineered graft materials. As part of this quest, we developed apatite-based bone scaffolds
through a VA SPiRE Grant (# 1I21RX003328-01A1). Our data showed that, in 12-weeks, the pores within the
fluorapatite scaffolds became completely filled with viable new bone tissue, demonstrating the efficacy of these
scaffolds in regenerating bone tissues. To further develop this novel material for clinical applications as an
“autograft-like” bone scaffold for the repair of critical-size defects, we propose combining our scaffold with stromal
vascular fraction cells as an osteogenic cell source. Thus, it is hypothesized that fluorapatite (FA)
scaffoldings seeded with patients’ own stem cells, contained within the stromal vascular fraction (SVF)
that is extracted from autologous fat tissue, will have the ability to generate new osseous tissue at a
level comparable to that of autograft bone in both a non-weight bearing critical-size defect model and a
weight-bearing fracture model. This hypothesis will be tested with three specific aims. Specific Aim 1 will
determine the optimal number of SVF cells needed for repairing bone defects in a rat model. Specific Aim 2 will
investigate the osteogenic potential and time-course of bone regeneration of FA scaffolds, with and without SVF,
in a critical size bone defect in a sheep ilium model. mRNA-based techniques will be used to highlight the
mechanistic differences in bone regeneration as a secondary outcome in the latter time-course study. Finally,
Specific Aim 3 will investigate the efficacy of the FA scaffolds, with and/or without SVF, in a sheep weight-
bearing tibial fracture model. FA with and without SVF will be compared to the clinical gold standard, autograft,
as well as FDA-approved hydroxyapatite scaffold. It is expected that such a combination treatment of SVF and
FA scaffolds will provide a potential source of “off-the-shelf” scaffolding materials for clinical bone repair and
regeneration and improve the health and quality of life for a significant number of military personnel, veterans,
and civilians requiring skeletal reconstruction.

Public health relevance
There is a rapidly increasing clinical demand for bone grafting materials for use in osseous regeneration and repair surgeries. Although autografts (from self) and allografts (cadaver) are the currently preferred options, each has its own drawbacks, including limited resources. A potential solution to overcome this graft material shortage is to develop equivalent engineered bone substitutes. This study is designed to test the efficacy of one such bone substitute, a fluoridated calcium phosphate-based bioceramic. In our initial studies, fluorapatite was shown to enhance in vitro differentiation of osteoblasts and stem cells into the osteogenic lineage, but more importantly, resulted in ~90% new bone formation in both, in vivo rat and pig models. The proposed study is designed to develop an autograft-like bone scaffold by incorporating a FA scaffold with a recipient’s own stromal vascular fraction cells—derived from a recipient’s fat tissue—to fill critical-size bone defects. If proven, this combination approach may become “off-the-shelf” autograft-like bone scaffolds for orthopedic and dental applications.